Deciphering the role of regulatory T cell derived Mmp12 in lung injury resolution

ABSTRACT
Acute Respiratory Distress Syndrome (ARDS) is characterized by heightened lung inflammation and edema in
the alveoli and interstitium, affecting the lung's primary function of gas exchange. The treatment for ARDS has
improved over the years, but the mortality of 20-40% is still associated with ARDS, and the residual defects in
lung function in survivors create a critical need for additional therapies. T regulatory cells (Tregs) are emerging
as a therapeutic area of interest to facilitate lung resolution due to their reparative and anti-inflammatory
properties. Previous work of my sponsor, Dr. Jason Mock, has associated a higher percentage of Tregs in the
CD4+ lymphocyte population in the bronchoalveolar lavage fluid (BALF) of patients with ARDS with time to
liberation from mechanical ventilation; moreover, in recent years, clinical trials for Treg cell therapy for ARDS
have been initiated. However, to realize the full potential of these therapies, we must understand the specific
mechanisms by which Tregs facilitate and promote resolution and repair. Our previous work identified the
transcript Mmp12 as upregulated more than twenty-fold in Tregs in lungs resolving from LPS-induced ALI
compared to Tregs from uninjured lungs. Mmp12's pleiotropic effects extend to the resolution of inflammation
by dampening neutrophil infiltration, clearing neutrophil extracellular traps (NETs), terminating complement
activation, and accelerating coagulation; however, Treg-derived Mmp12 has been largely unexplored. I
hypothesize that Treg-expressed Mmp12 promotes lung resolution by cleaving proinflammatory soluble
mediators and reducing the proinflammatory immune cell populations, thereby promoting optimal resolution
from lung injury. Aim 1 will determine the function of Treg-derived Mmp12 in the resolution of inflammation
during ALI induced by LPS or influenza. Parameters of inflammation and repair will be compared in mice with
Tregs lacking Mmp12 (TregMmp12-/- mice) to mice with Tregs expressing wild-type Mmp12. Aim 2 will determine
the substrates of extracellular Treg-derived Mmp12. These substrates will be identified by comparison of
cleaved substrates in TregMmp12-/- and control lungs during LPS- or influenza-induced ALI using N-TAIL
proteomics. Total Mmp12 protein concentration will be measured to determine the fraction of Mmp12 that Tregs
contribute. The kinetics of Treg-derived Mmp12 mRNA and protein expression and of substrate cleavage by
Treg-generated Mmp12 will be determined. The heterogeneity of Mmp12 expression by known Treg subsets
will be assessed. These studies will not only determine the role of Treg-derived Mmp12 by identifying specific
substrates that facilitate resolution but also elucidate the effects of Treg-derived Mmp12 in Treg biology and
function during lung injury and repair. Through this proposal, I will (1) develop laboratory skills, (2) improve my
scientific communication skills through presentations, manuscript preparation, and dissemination to the public,
(3) broaden my scientific background, as well as seminars series and workshops about lung disease, the
ethical conduct of research and career development.

Public health relevance
PROJECT NARRATIVE Treatment of ARDS is mainly supportive so the lungs can heal, even though factors such as age, lifestyle, and complications can limit the lung's ability to do so. There is a vital need for novel treatment methods to treat the pathology of ARDS directly, and Tregs have been identified as a promising approach. Identifying Treg mechanisms that are important to resolving lung injury will allow for a clearer understanding of how to employ Tregs effectively in therapeutic methods for patients with ARDS.